BIOINFORMATICS SHARED RESOURCE

INFORMATION SYSTEMS SHARED RESOURCE Kimberly Johnson, Director Cancer Center Information Systems is a Shared Resource providing integrated information systems in support of clinical and basic science biomedical research. The resource provides infrastructure, personnel, technical support, assistance and consultation in four areas - networks, databases, servers and web applications. The goal of the resource is to provide comprehensive computational support to enable researchers to use technology in the most efficient manner possible to accomplish their research goals. Cancer Center Information Systems is directed by Kimberly F. Johnson, under the administrative supervision of Dr. Stephen L. George, Director of Biostatistics. In addition to Ms. Johnson, CCIS has 16 full time staff. The resource provides database and applications development, web site support, server support and desktop support for 25 servers and for over 1000 users. In addition to network server support, CCIS supports largescale servers and software for the Biostatistics Shared Resource and the Bioinformatics Shared Resource. This group supports the informatics needs of a variety of research areas and programs. Support for the SPORES in Brain and Breast Cancer, the Cancer Genetics Network and the Protocol Office represent some of the larger efforts. CCIS is working closely with the Duke Health Technology Solutions group to integrate clinical data with research data. Support for the resource is provided through a combination of grant support, chargeback and institutional funding.